Identification of novel therapeutic combinations for NF2 schwannomas

PROJECT SUMMARY / ABSTRACT
Neurofibromatosis type 2 (NF2) is an autosomal dominant cancer predisposition syndrome characterized by
germline haploinsufficiency at the NF2 locus, which encodes Merlin. NF2 patients characteristically develop
bilateral vestibular schwannomas (VS) and spinal schwannomas as a result of loss of heterozygosity of NF2 in
Schwann cells or Schwann cell precursors. Although these tumors are largely benign, their growth can result in
significant neurological deficiencies including, but not limited to, deafness, vertigo, facial muscle weakness,
chronic neuropathic pain, and death. Because of the extensive morbidity associated with surgical removal of
these tumors, there is an urgent need to develop pharmaceutical approaches to halt or reverse the progression
of tumor growth in these patients. To date, no long-term effective therapies exist for these highly debilitating
tumors.
Given the challenging clinical trial logistics in a rare tumor predisposition syndrome such as NF2, it is
critical to establish a strategy linking preclinical and clinical studies for rapid translational innovation and
efficiency. We have developed genetically engineered mouse models (GEMMs) of NF2 that accurately
recapitulate tumor growth kinetics and histopathologic characteristics observed in NF2 patients—VS and
paraspinal schwannomas with 100% incidence, combined with progressive hearing loss that occurs with VS
formation. Using the Nf2 GEMM, we determined that the FDA approved multi-receptor tyrosine kinase (RTK)
inhibitor brigatinib reduced schwannoma tumor size and tumor number. Brigatinib is approved to treat
cancer driven by another kinase, anaplastic lymphoma kinase (ALK) and two ALK inhibitors, crizotinib and
brigatinib, have both shown preclinical efficacy against NF2-associated schwannomas and are under
evaluation in active clinical trials. While our findings suggest a role for FAK1 in modulating tumor progression,
our understanding of the role of FAK1 as a single target for NF2 tumors or in combination with other drug
targets is incomplete. We propose to build on our recent preclinical work by genetic ablation of FAK1 (Ptk2)
in murine (Nf2) and human (NF2) deficient Schwann cells to establish the role of FAK1 (Ptk2) in promoting
the genesis of Nf2 deficient schwannomas and associated morbidities (Aim 1). Drug synergy screening with
post-IND FAK inhibitors alone and in combination with RAF, MEK, and BET bromodomain inhibitors to
target cooperating Merlin-regulated pathways (Aim 2), and unbiased CRISPR-Cas9 kinome knockout screening
in murine and human cells to identify FAK1-dependent kinase vulnerabilities that can be exploited
therapeutically, alone or in combination (Aim 3). Our overarching goal with experiments in this application is
to identify drugs or drug combinations that could expediently proceed to phase I/II clinical trials for patients
with this debilitating neurological disease.

Public health relevance
PROJECT NARRATIVE This application focuses on using genetically engineered mouse models and cell culture models of neurofibromatosis type 2 to characterize the role of focal adhesion kinase (FAK) signaling in the development of NF2-related schwannomas. These complementary in vitro and in vivo studies will determine the genetic contribution of FAK1/PTK2 in schwannoma development, the potential utility of post-IND FAK inhibitors, alone or in combination with other phase I/II or FDA approved kinase inhibitors, and molecular response signatures to treatment. Collectively, the genetic, pharmacologic, and genomic approaches will enable rapid translation to early phase clinical trials for NF2 schwannoma patients who currently lack effective targeted therapy options.